A Spatially Uniform Illumination Source for Widefield Multi-Spectral Optical Imaging

Project Summary
The main objective of this proposal is to develop a new multi-spectral light source with exceptional illumination
uniformity we call “Effective Uniform Color-Light Integration Device (EUCLID)” for biological imaging applications.
Our project's primary goal is to show how EUCLID impacts multispectral imaging applications and validate in
mesoscale brain imaging, a popular neurophotonics application. We anticipate that EUCLID can be integrated
into a wide range of biological microscopic and mesoscopic imaging applications, including super-resolution
microscopy and birefringence microscopy. In biological widefield imaging application, illumination homogeneity
is a crucial factor for excitation performance and resulting data quality. Yet, due to spatial and spectral non-
uniformity of conventional imaging systems caused by imperfect optical components, illumination corrections
require sophisticated solutions. Illumination design for multi-spectral imaging (MSI) is particularly challenging as
field uniformity across a wide range of wavelength is essential. Recent advancements in light emitting and laser
diode technology enables creation of multi-spectral light sources with previously unattainable compactness,
power, and controllability. Traditionally, achieving homogenous illumination at several wavelengths requires
combining collimated beams using dichroic mirrors or beam-splitters and precise alignment. Cost, complexity,
and absolute size of the illumination solution require careful consideration when developing a MSI application.
The significant novelty of EUCLID is the introduction of a conical geometry allowing for light integration, design
optimization and uniformity adjustments. The diffuse-reflective adjustable hollow cavity used in EUCLID alters
the source field distribution to compensate spatial non-uniformity caused by the imaging system's optical
components while allowing for uniform mixing of light from discrete sources with great efficiency. With a maximum
spatial deviation of 1% over a large field of view, preliminary experiments show significantly improved illumination
for multispectral imaging in both Nelsonian (critical) and Koehler configuration (FOV). EUCLID is also shown to
provide speckle-free laser illumination over a wide field-of-view with a plateau uniformity around 2% for a broad
spectrum. This uniformity introduced by the EUCLID is 3 times better than current state-of-the art flat-top
illumination technique. In this proposal, we propose to show EUCLIDs performance in multispectral mesoscale
brain imaging where neuronal activity (calcium signals), hemodynamic activity (hemoglobin oxygenation), and
neuromodulation (acetylcholine levels) are simultaneously monitored across the dorsal cortex of mice with
implanted ‘crystal skull’ windows. For that, we will develop two different EUCLID designs. The first one will accept
two different commercial LED bulb to provide oblique excitation light to monitor neuronal activity. The latter one
will integrate two different laser source and provide speckle-free uniform illumination to detect hemoglobin
oxygenation. We formed a partnership with Boston University's Neurovascular Imaging Laboratory and
Neurophotonics Center allowing us to showcase how EUCLID can be used in biological imaging applications.

Public health relevance
Project Narrative We aim to demonstrate a new multi-spectral light source with remarkable illumination uniformity we call Efficient Uniform Color-Light Integration Device (EUCLID) and its potential impact in a broad range of biological microscopic and mesoscopic imaging applications. EUCLID employs a diffuse-reflective, adjustable hollow cavity for uniform mixing of light from discrete sources with high efficiency and provides a simple method to compensate for spatial non-uniformity introduced by optical components in the imaging system. We propose to apply EUCLID to multispectral mesoscale imaging of neuronal and hemodynamic activity and neuromodulation in the cortex of awake mice implanted with crystal skull windows.